Global Health Catalyst (GHC) Summit

Project Summary
Recently, leaders in cancer policy from the USA and 14 economically diverse countries concluded
that successful campaigns to control cancer will increasingly depend on concerted international
collaborations. The recent World Health Organization Cancer Report highlights urgency for such
international collaborations, with over 60% of 14 million new cancer cases and 70% of 8.2 million
deaths per year occurring in low and middle income countries (LMIC), some of which, sadly, are
the least capable of dealing with cancer without some form of collaboration. These major
disparities in cancer deaths are in part a reflection of poignant underlying disparities in Radiation
Oncology. For example, radiotherapy, which is needed in the treatment of over 50% of cancer
patients, is not available in about half of Africa's 54 countries, and preliminary research shows
major safety concerns in implementation of radiotherapy where available. The overall goal of this
proposal is to organize yearly global health catalyst (GHC) cancer summits designed to catalyze
high impact international collaborations between US and African Institutions to address the
growing global burden of cancers, and associated disparities. This GHC summits, will build on
the success and lessons learned over the past years during previously organized summits, that
have catalyzed collaborations to support cancer healthcare institutions in different African
countries, supported education and training efforts to build human/research capacity, and
established fecund research collaborations, along with disease prevention and advocacy
programs in global oncology. An innovative component of the summit is the focus on outreach
engagement of under-represented minorities and the resource-laden Africans in Diaspora (AiD)
to turn the devastating effects of brain drain to gain against cancer. Outcomes will include: new
and strengthened collaborations involving partners from both USA and African institutions each
year, significant increase in participation of under-represented minorities and diaspora in global
oncology, peer-reviewed publications co-authored by both USA and African collaborators, joint
patents resulting from research collaborations, and continuous growth to engage more
participation from USA and African Institutions to address the growing global burden of cancer
and associated disparities.

Public health relevance
Project Narrative The overall goal of this project is to organize Global Health Catalyst cancer summits which will catalyze sustainable high impact USA-Africa collaborations designed to significantly enhance cancer research and education benefiting both USA and African countries. An innovative component of the summits is the focus on unprecedented engagement of under-represented minorities and the Diaspora to catalyze or support these collaborations.